IGF::OT::IGF DEVELOPMENT & CHARACTERIZATION, FDA-COMPLIANT ELECTRONIC VAPOR-BASED COMBINATION PRODUCT, POP: 9/15/2015-5/14/2016, N43DA-15-8930, SBIR I BASE AWARD

Development, Manufacturing and Testing Nicotine e-liquid formulations to support CDER DMF submission. Development of a Standardized ENDS Device suitable for GMP manufacturing.